Multi-scale analysis of single cell sequencing data to dissect the complexity of influenza infections

Project Summary Emergent viral infections, such as SARS-CoV-2 and new influenza strains, pose an enormous health and economic burden on patients and the society. Viral cycles between the animal reservoir and the human population cause millions of hospitalizations and thousands of deaths each year, especially in high-risk groups, such as elderly, pregnant women, obese individuals with a compromised immune system, and indigenous populations. Disease morbidity and mortality increase after interspecies transmission of a new viral strain, and becomes capable of infecting humans. In this case, there is no (or minimal) pre-existing antibody-mediated immunity to the new viral strain at the population level, leading to millions of infections and, ultimately, a pandemic. In the absence of antibodies, the severity of the disease can be ameliorated by broadly cross-reactive cellular immunity. However, the precise mechanism of how immune cells mediate recovery in some individuals, but not others, is far from clear. Fortunately, a diverse and rich collection of publically available datasets can be leveraged to thoroughly investigate the specific molecular mechanisms of viral infection and host response. Gene expression profiles from human cohorts and animal studies in GEO/SRA, immunological profiles in ImmPort or viral strain data, and interaction with immune epitopes in the Influenza Research Database (IRD) or the Virus Pathogen Database and Analysis Resource (ViPR), both Bioinformatics Resource Centers (BRC) of NIAID, are examples of such resources. In particular, high-resolution single-cell RNA-seq data enables us to study relevant processes during influenza and SARS-CoV-2 infections in greater detail. The overarching hypothesis of our proposed work is that diversity in virus strains, genetic immune epitopes, and responding immune cells contributes to heterogeneous outcomes of viral infection. By integrating all existing large-scale single-cell and bulk transcriptomic data in SARS-CoV-2 and influenza infections, we aim to identify determinants of viral infections and key processes underlying viral replication, and immune response using integrative multi-scale network biology approaches. The proposed research highlights the importance of identifying relevant key-immune processes at a single-cell resolution that control the infection and limit the extent of inflammatory damage. Such findings will significantly improve therapeutic options in the fight against these threatening infectious diseases. All the models and the software tools developed through this project will be shared with the community.

Public health relevance
Public Health Importance – Viral infections cause significant morbidity and mortality annually. Circulating influenza viruses infect up to 15% of the world population and cause an average of 36,000 deaths and more than 200,000 hospitalizations annually – only topped by the current COVID-19 pandemic with 84M cases and almost 2M deaths worldwide, as of end of the year 2020. The proposed research highlights the importance of identifying key-immune processes that control the infection and limit the extent of inflammatory damage. These findings will significantly improve therapeutic options in the fight against these threatening infectious diseases.